Evaluation of PrEP implementation strategies for the general population in Botswana

PROJECT SUMMARY
While Botswana has attained the UNAIDS 95-95-95 target for HIV treatment and is the first country with
severe HIV epidemic to reach the milestone of elimination of mother-to-child HIV transmission, the country
failed to achieve the national target of zero new HIV infections by 2016 and is equally unlikely to achieve
the UNAIDS target of zero HIV infection in Botswana by 2030. In 2021 alone, Botswana registered ~6,700
new HIV infections. The initial Botswana PrEP strategy focused on key populations (KP) including
adolescent girls and young women (AGYW) with primarily HIV clinic based PrEP dispensing, and the
general heterosexual population was not prioritized. In Botswana and the region, barriers to PrEP uptake
or persistence include competing needs, mobility, poor knowledge about PrEP, limited social support for
PrEP users, among others. New strategies to remove barriers related to PrEP knowledge, access, and
uptake are urgently needed because there are individuals at substantial risk for HIV even in low incidence
settings. Thus, in the proposed research, we will develop and test new strategies that target a younger,
mobile, heterosexual and digitally connected population with high rates of sexual concurrency. Our
proposed study will leverage a successful national ART program and infrastructure to first develop and
pilot a PrEP implementation strategy for the general population. The program will be developed in
collaboration with policy makers, healthcare providers, community leaders, information & communications
service providers and adults between 18 and 49 years old in Botswana. It is intended to be delivered in-
person and also using information and communications technology such as cellular, video or WhatsApp.
Following the pilot, we will then use the new implementation strategy to conduct a type 3 hybrid multi-
component cluster randomized trial to optimize evidence-based implementation (EBI) uptake and
improvement of PrEP.

Public health relevance
Lack of effective HIV pre-exposure prophylaxis (PrEP) programs is a significant contributor to ongoing spread of HIV in sub-Saharan Africa (SSA). Our proposed study, to be conducted in Botswana, will leverage a successful national ART program and infrastructure to first test a set of strategies for the general population (18-49 years old) to increase PrEP uptake using information and communications technology to expand reach, reduce barriers due to mobility and competing needs for work. Based on lessons learnt from the preliminary study, we will then assess if PrEP uptake and persistence will be better with the new strategies as compared to the way PrEP is currently being offered in Botswana.